Epithelial abnormalities in IPF: role of ER stress and GRP78/BiP

DESCRIPTION (provided by applicant): Idiopathic pulmonary fibrosis/usual interstitial pneumonia (IPF/UIP) is a devastating interstitial lung disease of unknown etiology, characterized by (myo)fibroblast activation/proliferation, extracellular matrix (ECM) deposition and progressive lung destruction. A central role for alveolar epithelium in IPF/UIP pathogenesis has recently been postulated. In this paradigm, injured alveolar epithelial cells (AEC) actively participate in fibrogenesis by releasing fibroproliferative mediators that promote proliferation an differentiation of fibroblasts that in turn induce AEC apoptosis and/or giving rise directly to fibroblasts through epithelial-mesenchymal transition (EMT). However, mechanisms underlying AEC injury/activation and downstream molecular pathways linking epithelial abnormalities to fibrosis remain unclear. Association between endoplasmic reticulum (ER) stress and both sporadic and familial pulmonary fibrosis associated with surfactant protein (SP) mutations has been reported. We recently found that ER stress triggers protective signaling known as the unfolded protein response (UPR) and induces both apoptosis and EMT in AEC in vitro via activation of the non-receptor membrane-associated tyrosine kinase Src, supporting a causal role for ER stress in the dysfunctional AEC phenotype in pulmonary fibrosis. Preliminary data suggest that reactive oxygen species (ROS) and b-catenin activation/interaction with the co-activator CBP are involved in Src-dependent signaling. The ER chaperone glucose-regulated protein 78 (GRP78) is a master regulator of ER homeostasis and thus represents an ideal target with which to modulate ER stress responses in alveolar epithelium. The overall goals of this proposal are to investigate mechanisms underlying ER stress-induced epithelial abnormalities implicated in the pathogenesis of fibrosis by modulating GRP78 utilizing mice with lung epithelial cell-specific deletion of Grp78. We hypothesize that (1) loss of Grp78 induces and/or exacerbates experimental fibrosis in vivo; (2) GRP78 insufficiency-induced epithelial injury contributes to fibrosis via direct effects on the epithelium (e.g., apoptosis/EMT) and/or abnormal epithelial-fibroblast crosstalk; and, (3) effects of GRP78 insufficiency on EMT/fibrosis are mediated via Src and/or ROS-dependent β-catenin/CBP signaling. We will use AEC-specific Grp78 knockout mice, in conjunction with clinically relevant mutant SP-CΔexon4, our well- established primary AEC in vitro monolayer model, and ICG-001, a novel inhibitor of β-catenin/CBP interaction, to address the following Specific Aims: 1. Evaluate effects of ER stress mediated by loss of Grp78 on pulmonary fibrosis in inducible AEC-specific Grp78 knockout mice; 2. Investigate the role of ER stress in AEC abnormalities (apoptosis vs EMT vs aberrant epithelial-fibroblast crosstalk) implicated in fibrosis in inducible AEC-specific Grp78 knockout mice; and 3. Determine mechanisms underlying ER stress-induced AEC injury/fibrosis. These studies will provide insights into mechanisms underlying the pathogenesis of IPF and facilitate identification of novel therapeutic targets for this incurable disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: It is becoming apparent that injury to cells lining the airspaces of the lung (called epithelial cells) is a major causative factor in formation of scar tissue (fibrsis) in the lung in a disease called idiopathic pulmonary fibrosis (IPF). Recently it has been shown that activation of a part of the cell known as the endoplasmic reticulum (ER) may injure epithelial cells by inducing a condition known as ER stress. Our overall objective is to understand how ER stress in epithelial cells leads to formation of scar-forming cells in order to understand its rolein fibrosis and elucidate new treatment strategies for this otherwise fatal disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Idiopathic pulmonary fibrosis/usual interstitial pneumonia (IPF/UIP) is a progressive fibrotic lung disease of unknown etiology, characterized by fibroblast/myofibroblast accumulation and extracellular matrix (ECM) deposition leading to tissue destruction and loss of lung function. To date, there is no effective therapy for this disorder. Evidence of epithelial abnormalities in IPF (e.g., reactive pneumocytes and increased apoptosis) has led to the notion that ongoing epithelial injury and abnormal wound repair play central roles in disease pathogenesis, with accumulation of (myo)fibroblasts attributable to (a) dysregulated epithelial-fibroblast crosstalk and resulting activation of resident fibroblasts/bone marrow-derived circulating cells and/or (b) epithelial-mesenchymal transition (EMT). Regardless of the origin of fibroblasts/myofibroblasts, mechanisms underlying AEC injury/dysfunction are poorly understood. Endoplasmic reticulum (ER) is crucial for synthesis/folding of cellular proteins. Perturbation of the ER luminal environment can lead to accumulation of misfolded proteins. An adaptive signaling cascade known as the unfolded protein response (UPR) is activated to restore ER homeostasis. ER stress results when the ability of the ER to process the load of misfolded proteins is exceeded and, if excessive or sustained, leads to apoptosis. ER stress triggers generation of reactive oxygen species (ROS) and oxidative stress, which in turn activates the UPR, indicating bidirectional crosstalk between these pathways. In lung, an association between ER stress and both sporadic and familial pulmonary fibrosis due to surfactant protein (SP) mutations has been reported. We recently demonstrated that ER stress induces both apoptosis and EMT of alveolar epithelial cells (AEC) in a dose-dependent manner via activation of the non-receptor membrane-associated tyrosine kinase Src, supporting a causal role for ER stress in epithelial dysfunction observed in pulmonary fibrosis. In addition, our preliminary studies suggest that EMT is prevented by treatment with the antioxidant N-acetylcysteine, suggesting a role for ROS in activation of Src and/or induction of EMT, while effects downstream of Src involve b-catenin activation and selective interaction of b-catenin with the coactivator CBP. The overall goals of this proposal are to investigate mechanisms underlying ER stress-induced epithelial abnormalities implicated in the pathogenesis of fibrosis by modulating a key UPR signaling component, the ER chaperone glucose-regulated protein 78 (GRP78), utilizing mice with lung epithelial-specific deletion of Grp78. GRP78 is a master regulator of ER homeostasis. In response to ER stress, the UPR is activated by release of GRP78 from three transmembrane ER stress sensors to which it is bound. GRP78 is also upregulated to assist in protein folding and targeting of misfolded proteins for degradation. Thus, GRP78 represents an ideal target with which to modulate ER stress in alveolar epithelium in order to investigate the role of ER stress in epithelial abnormalities in fibrosis. We will address the hypotheses that (1) loss of Grp78 induces and/or exacerbates experimental fibrosis in vivo; (2) GRP78 insufficiency-induced epithelial injury contributes to fibrosis via direct effects on the epithelium (e.g., apoptosis/EMT) and/or abnormal epithelial-fibroblast crosstalk; and, (3) effects of GRP78 insufficiency on EMT/fibrosis are mediated via Src and/or ROS-dependent b-catenin/CBP signaling. We propose the following Specific Aims: Aim 1. Evaluate effects of ER stress mediated by loss of Grp78 on pulmonary fibrosis in inducible AEC-specific Grp78 knockout mice 1.1. Determine if GRP78 insufficiency promotes age-dependent spontaneous lung fibrosis 1.2. Investigate if GRP78 insufficiency sensitizes to fibrosis due to additional insults/ER stress (e.g., overexpression of SP-CΔexon4 ) Aim 2. Investigate the role of ER stress in AEC abnormalities (apoptosis vs EMT vs aberrant epithelial- fibroblast crosstalk) implicated in fibrosis in inducible AEC-specific Grp78 knockout mice 2.1. Evaluate effects of Grp78 knockout on susceptibility to epithelial cell apoptosis at baseline and following challenge with ER stress inducers (e.g., mutant SP-CΔexon4) 2.2. Examine effects of GRP78 insufficiency on induction of EMT at baseline and following challenge with ER stress inducers (e.g., mutant SP-CΔexon4) 2.3 Determine effects of Grp78 knockout on aberrant epithelial-fibroblast interactions at baseline and following challenge with ER stress inducers (e.g., mutant SP-CΔexon4 ) Aim 3. Determine mechanisms underlying ER stress-induced AEC injury/fibrosis 3.1 Evaluate the roles of ROS and Src activation and β-catenin/CBP interaction in mediating ER stress- induced EMT in AEC in vitro 3.2 Investigate effects of blocking ROS generation or β-catenin/CBP interaction in ER stress-induced fibrosis/EMT in vivo